A novel anti-inflammatory role for the neutrophil NADPH oxidase

Project Summary Local and systemic inflammatory events elicit immune activation in the host to provide the necessary pro- inflammatory response based on the danger sensed, followed by active resolution and return to baseline. One common clinical example of this process is the Systemic Inflammatory Response Syndrome (SIRS), which can be activated following a range of insults that may include infection, shock, allergic reaction, or trauma. This pro- inflammatory phase of the immune response is overlapped by a compensatory anti-inflammatory response that restores immune homeostasis. Circulating neutrophils (PMN) are critically involved in mediating the consequences of systemic inflammation, in part by the generation of reactive oxygen species (ROS). PMN produce ROS via activation of the NADPH oxidase (Nox), with Nox2 (gp91phox) being the catalytic subunit in this cell type. Despite the unequivocal requirement for neutrophil-derived ROS in microbial defense, it is clearly recognized that PMN activation can lead to host tissue damage. This well-studied proinflammatory activation of PMN is counterbalanced against recent evidence supporting an anti-inflammatory role for Nox2. The current proposal focuses on defining cellular effects and molecular targets of ROS signaling in resting PMNs, and investigation of an anti-inflammatory role of Nox2 in termination of inflammation. These goals are predicated on two subsets of strong preliminary data: 1) demonstration of specific pro-inflammatory phenotypic alterations in resting PMNs in the absence of NADPH oxidase function, and 2) enhanced and persistent inflammation and increased mortality in Nox2-deficient mice using a murine model of sterile generalized inflammation. The overall hypothesis of this proposal is that Nox2 in PMN has an essential anti-inflammatory role in the regulation of the host inflammatory state. Furthermore, we hypothesize that Nox2-derived ROS are required both to maintain resting cellular quiescence and to return to homeostasis following an inflammatory insult. These hypotheses will be tested with the following aims: 1) Nox2 is active in unstimulated PMN and necessary to maintain the resting cell phenotype. 2) Nox2 has anti-inflammatory effects in PMN mediated via the p38 mitogen-activated protein kinase (MAPK) pathway. The approach to these aims will include sophisticated analysis of subcellular vesicles/endosomes of unstimulated human PMN for evidence of assembly and activation of Nox2. In addition, focused exploration of cellular targets of anti-inflammatory ROS signaling, and downstream consequences of this signaling will be undertaken. Primary human PMNs will be used for in vitro analyses of signaling pathways and confocal microscopy will be employed to localize ROS signals. A better understanding of the cell biology of host inflammation will be relevant to numerous disease processes.

Public health relevance
Relevance to Public Health: The systemic inflammatory response syndrome continues to be a major challenge in intensive care medicine with unacceptably high mortality. Mechanisms by which host cells resolve both local and systemic inflammatory events, and return to homeostasis are poorly understood. The proposed studies will advance our fundamental knowledge of the function of neutrophil signaling in the regulation of the host inflammatory state as a component of normal immune system function and in the pathogenesis of local and systemic inflammatory events.